Telehealth-delivered peer support to improve quality of life among Veterans with multimorbidity

Background: More than 50% of Department of Veterans Affairs (VA) patients have multimorbidity: the co-
occurrence of >2 chronic conditions. Multimorbidity impairs health-related quality of life (HRQoL); leads to
psychologic distress, disability, and mortality; and contributes to high health care utilization and costs. Most
chronic conditions require patients to engage in disease self-management, including adhering to treatments,
making lifestyle changes, and working with their health care team. Patients with multimorbidity face many
barriers to self-management and to attending in-person clinic visits. Given the limited time and competing
demands of primary care visits, patients with multimorbidity need additional support for self-management. Peer
support – assistance provided by non-professionals who are similar to the populations they serve – delivered
via telehealth is suited to address these needs. We developed a virtual, Veteran-led peer health coaching
intervention, VetASSiST (Veterans Activating Social Support for Self-management and Treatment
engagement), to help patients with multimorbidity overcome barriers to self-management and improve HRQoL.
Significance: VetASSiST is timely and efficient and aligns with the HSR&D priority that improving care should
support coordination and integration of care for the majority of Veterans who have multiple conditions rather
than building new single disease interventions. The proposal also aligns with other HSR&D priorities of Primary
Care Practice and Management of Complex Chronic Diseases and Virtual Care/Telehealth.
Innovation and Impact: Prior peer support trials address individual chronic conditions or mental health.
VetASSiST will be one of the first trials of an intervention to support Veterans with multimorbidity. It will also be
one of the first to leverage telehealth to remotely deliver peer support, which has the potential to increase
access to care. If effective, the intervention could be broadly implemented to improve patient outcomes.
Specific Aims: 1) Test the effect of VetASSiST, compared to usual care, on the primary outcome of baseline
to 12-month change in physical HRQoL, and secondary outcomes of mental HRQoL and health care utilization;
2a) Describe differences between VetASSiST and usual care on baseline to 12-month changes in intermediate
outcomes reflecting the functions of peer support and intervention targets: self-efficacy, patient activation,
health behaviors, social support, perceived access to care, patient-provider communication, and shared
decision-making; 2b) Examine whether intermediate outcomes mediate intervention-associated differences in
HRQoL; 3) Evaluate feasibility of translating VetASSiST into practice, including evaluation of per patient
intervention costs and barriers and facilitators to implementation.
Methodology: We plan a hybrid type 1 implementation-effectiveness randomized controlled trial of 320
Veterans with complex multimorbidity, defined as >3 chronic conditions in >3 body systems. Patients must also
have >1 of: 1) physical and mental health conditions; 2) frailty; 3) frequent emergency care; 4) polypharmacy;
or 5) high treatment burden. We will identify eligible patients using data from the electronic health record,
confirmed with self-reported information at screening, and will randomize enrolled patients 1:1 to VetASSiST or
usual care control. The primary outcome is change in physical HRQoL from baseline to 12-months, measured
with the SF-12. Secondary outcomes include change in mental HRQoL (SF-12) and health care utilization.
Guided by the RE-AIM framework, we will use quantitative and qualitative methods to assess barriers and
facilitators to implementation among key stakeholder groups. These data will inform future implementation.
Next Steps/Implementation: This hybrid type 1 trial will provide data needed to prepare for broader VA
implementation if the intervention is effective. Implementation activities will be coordinated with existing local
and national operational partners. If the intervention is not effective, Aims 2 and 3 will elucidate how Veterans
with multimorbidity could be better supported in the future.

Public health relevance
Multimorbidity is common among Veterans and results in poor health-related quality of life (HRQoL) and contributes to high health care utilization and costs. Patients with multimorbidity need to engage in self- management for many of their chronic conditions. Patients with multimorbidity experience significant barriers to self-management and, due to limitations of traditional primary care visits, they need supplementary support to optimally engage in self-management. Peer support delivered by trained Veteran peer health coaches is well suited to fill this need. Limited research has evaluated the effectiveness of peer support in the context of multimorbidity. The proposed study seeks to evaluate whether a telehealth-delivered peer health coaching intervention improves HRQoL compared to usual VA care among high-risk patients with multimorbidity. It also aims to understand barriers and facilitators to implementing the program in VA if it is effective. This research may enhance VA’s ability to provide services to Veterans with multimorbidity and improve health outcomes.